CENTER FOR PERCEPTION AND COMMUNICATION IN CHILDREN

PROJECT SUMMARY/ABSTRACT No change by the proposed supplement activities for (5P20GM109023-08).

Public health relevance
PROJECT NARRATIVE No change by the proposed supplement activities for (5P20GM109023-08).